Sociocultural Shifting, Sleep and Cardiometabolic Risk in African-American Women

PROJECT SUMMARY
African-American women have strikingly high rates of coronary heart disease (CHD)-related death and
disability compared to women of all other racial/ethnic groups. This excess burden has persisted for decades,
and is on the rise among young to middle-aged women. Emerging evidence suggests that sleep disturbance
(e.g., short sleep duration, poor sleep continuity) may be an important driver of CHD risk in African-American
women; however, because most research on sleep disturbance in African-American women has focused on
comparisons to women from other racial/ethnic groups, there are substantial gaps in knowledge about factors
that might promote and protect against sleep disturbance within African-American women. Such information
will be critical for the development of targeted intervention efforts to improve sleep and ultimately reduce CHD
risk in this population. The proposed project is designed to examine whether and how “Shifting” -- a novel,
sociocultural phenomenon hypothesized to be salient among African-American women-- might impact sleep
disturbance among this group. Shifting is defined as a seemingly adaptive practice in which African-American
women engage in self-altering behaviors to both fit in with dominant society and accommodate African-
American men. Although documented in qualitative studies and anecdotal accounts of African-American
women’s experiences over the past 30 years, empirical studies of shifting have only recently emerged, and
none have focused on health. We have compelling preliminary data on early middle aged African-American
women, indicating that reports of Shifting (e.g., changing speech patterns, downplaying accomplishments, self-
silencing) are associated with subjective sleep disturbance and body mass index (BMI), not explained by
depressed affect, or discriminatory or other chronic stressors. Building on this preliminary data, we will
examine the prospective interrelationships among shifting, day-to-day psychological processes, and sleep
disturbance in 400 African-American women aged 35-54 from a range of SES backgrounds. Shifting and
subjective sleep quality will be measured with validated questionnaires, and sleep duration and continuity will
be assessed via actigraphy over the course of 14 days at baseline, and in order to shed some light on
temporality, at a 12-month follow up. In order to provide us with a more in-depth understanding of how shifting
might contribute to sleep disturbance on a night-to-night basis, reports of day-to-day stress, negative affect and
vigilance will be assessed via daily diaries concurrent with the actigraphy assessment over the 14-day period.
Finally, we will examine whether our hypothesized relationships are exacerbated by socioeconomic status
(SES), which might increase the likelihood of Shifting, or ameliorated by resilience factors that promote positive
social interactions and self-care (emotional support, religious service attendance, self-compassion). An
exploratory Aim will also examine linkages between Shifting, sleep disturbance, and CHD risk.

Public health relevance
PROJECT NARRATIVE African-American women have disturbingly high rates of CHD relative to women of other racial/ethnic backgrounds, and sleep disturbance is hypothesized to be an important driver of this excess risk. Yet the determinants of sleep disturbance in African-American women remain poorly understood. The goal of the proposed research is to determine whether and how “shifting,” a commonly described, but understudied phenomenon with high relevance for African-American women, might be associated with sleep disturbance and elevated CHD risk in this group.